COMPARISON OF TWO REGIMENS OF PROPHLACTIC ANTIBIOTICS IN PEDIATRIC ORTHO SURGERY

This study is designed to compare the current practice of 48 hour duration of prophylaxis with the CDC recommended pre- and intra-operative dosage and to determine if there is any difference in the effectiveness in preventing post-operative wound infections.